Development of a novel, patient-centered measure of reproductive autonomy in the healthcare context

ABSTRACT
The United States has among the worst maternal and infant outcomes of developed countries, which are
disproportionately experienced by people who are racial or ethnic minorities, poor, and/or have chronic
medical illnesses. The ability for women to actualize their reproductive decisions around pregnancy, pregnancy
prevention, and termination, may require the involvement of clinicians, who may (or may not) facilitate access
to reproductive services. Thus, to better understand the root causes of adverse maternal and perinatal
outcomes, we believe that the reproductive healthcare setting requires closer investigation. Studies
overwhelmingly suggest that people who are socially marginalized or have chronic and complex medical
illnesses experience negative reproductive health care encounters. Such encounters may prevent patients’
access to the information, services, and supports needed to make and execute reproductive decisions that align
with their values and priorities. Patients who perceive that their reproductive autonomy has been undermined
in the healthcare context may feel disempowered, distrustful of their clinicians and the health care
environment, and unlikely to follow clinical recommendations or receive follow-up care— all of which may have
deleterious effects on their health and well-being. Thus, the extent to which people experience reproductive
autonomy in healthcare settings may be a critical but understudied factor in understanding how the healthcare
environment may influence maternal health and outcomes. No quantitative measure exists to capture this
construct or link it to patient-centered or clinical outcomes. We therefore propose to develop a novel measure
of Reproductive Autonomy in Healthcare (RAH). We will refine our preliminary conceptualization of RAH
through qualitative interviews and concept mapping. We will use this framework to generate preliminary items
for the RAH measure. We will refine the items with guidance from an interdisciplinary panel of content experts
and cognitive interviews with patients. Finally, we will field test the RAH measure among reproductive-age
women who are socially marginalized and/or have chronic diseases to assess its acceptability and evaluate its
preliminary psychometric properties. In future work, we will validate the RAH measure in a large cohort of
diverse women and evaluate the potential roles of RAH as a mediator or moderator of downstream clinical
outcomes in women at high risk for preterm birth, and maternal morbidity and mortality.

Public health relevance
NARRATIVE Reproductive autonomy in the healthcare setting is the right for people to access health information, services, and supports that they need to make and execute reproductive decisions that are aligned with their values and priorities. Women who lack reproductive autonomy in healthcare settings may be less willing to engage in shared medical decision-making with clinicians or to receive preventive health care, particularly if from socially or medically marginalized populations; reproductive autonomy, if not supported in the healthcare context, may thereby lead to adverse clinical outcomes. We propose to develop a novel measure of reproductive autonomy in the healthcare context, and to assess its preliminary psychometric properties, that may be used to evaluate the relationships between this construct and downstream outcomes related to reproductive health and well-being.